Community-driven drug prevention implementation strategies for Native Hawaiian and Pacific Islander youth in rural Hawai'i

PROJECT SUMMARY/ABSTRACT
I am an implementation scientist, youth substance use and mental health services researcher, clinical
psychologist, and descendant of Okinawan-Japanese immigrants to Hawaiʻi. I propose to use a community-
based participatory research approach to study the implementation of a culturally grounded substance use
prevention curriculum, Ho`ouna Pono. The intervention has been created, evaluated, and spread through
several NIDA-funded grants to address the high rates of substance use in Native Hawaiian and Pacific Islander
youth, especially in rural areas. Our work has revealed that many implementation barriers intersect at the
youth, family, and teacher levels, indicating a pressing need for community-led implementation efforts. In this
Racial Equity Initiative Visionary Award, I propose an innovative combination of implementation science and
participatory methods to spread and sustain Ho`ouna Pono in the Windward District of the Hawaiʻi State
Department of Education. I hypothesize that Ho`ouna Pono adoption and sustainability will increase by using
community-led innovation tournaments, which actively promote engagement and ownership in the
implementation process. I also hypothesize that real-time assessments of implementation through ecological
momentary assessment will enable rapid and accurate implementation and intervention adaptation. These two
innovative approaches have never been tested for Native Hawaiian and Pacific Islander youth living in
geographically remote and rural areas, making this a novel high-risk, high-reward study. Moreover, this is the
first study to use ecological momentary assessment to facilitate implementation of youth substance use
prevention.
I intend to challenge the existing research paradigm through this Racial Equity Initiative Visionary
Award through redistributing power to community to lead the research effort. Traditionally, implementation
science and research has privileged the researchers' voice, often leading to highly controlled, community-based
studies that create mistrust in the scientific process and produce unsustainable interventions with limited
community acceptability. These concerns are even more pronounced in populations that have systematically
been the focus of increased scientific inquiry, like indigenous and rural populations. The impact of this
paradigm-shifting project has the potential to change how implementation research is conducted by putting
community in the leadership role. Furthermore, it will build scientific skills and expertise directly into the
community to foster ongoing implementation and generalizability toward future implementation efforts. It is
imperative that studies with the potential for reshaping institutional structures and systems be conducted to
further advance racial equity, especially for Native Hawaiian and Pacific Islander youth. The proposed study
addresses this imperative.

Public health relevance
PROJECT NARRATIVE This high-risk, high-reward proposal addresses racial health equity and challenges the typical scientific paradigm through innovative approaches in youth substance use prevention for Native Hawaiian and Pacific Islander (NHPI) rural populations. Implementation science and participatory methods will shift power, ownership, and responsibility from the project's inception to NHPI communities to actively promote adoption and sustainment of culturally grounded substance use prevention. Community-led innovation tournaments and ecological momentary assessment will produce new generalizable findings for other indigenous and underserved populations, promoting the spread and reach of culturally grounded substance use prevention.